Translation addiction and targeting in colon cancer

Summary
Colorectal cancer (CRC) represents a leading cause of cancer death in the US and worldwide, and its
development is driven by mutational activation of Wnt, RAS/RAF/ERK and PI3K/AKT/mTOR signaling. However,
targeting individual driver in CRC has limited success. Wnt, mTOR and ERK signaling converges to deregulate
eIF4F and lead to translate key oncogenic targets including c-Myc. Interestingly, phosphorylated eIF4E (S209,
or p-eIF4E) is dispensable for development or global translation, but required for transformation and optimal
tumorigenesis in some models. The underlying causes and significance of elevated p-eIF4E in human cancer
and oncogenic translation remains largely unknown. Our novel preliminary data and recent publications supports
a critical role of p-eIF4E in human and mouse colon cancer development, and in regulating colon cancer
proliferation via ATF4-mediated metabolic and stress adaptation. Pharmacological targeting of eIF4E/4F
induces endoplasmic reticulum stress and CRC cell death in culture and in vivo. The central hypothesis of the
project is that phosphorylated eIF4E drives colon cancer initiation and progression through ATF4-dependent
metabolic and stress reprogramming and serves as an actionable and druggable vulnerability. We will test this
hypothesis in three specific Aims. SA1. Define the role of eiF4E phosphorylation in colon cancer development.
SA2. Elucidate the mechanisms of p-eIF4E-dependent oncogenesis in colon cancer. SA3. Target eIF4F/4E in
colon cancer therapy. The proposed work will develop and employ innovative tools, including phosphorylation
defective eIF4E cancer cells and mice, clinical samples, and highly mechanistic and comprehensive approaches
to define the role of p-eIF4E in colon cancer biology and therapy. If successful, our work will provide a better
understanding of oncogenic translation in protective stress and metabolic adaptation, as well as strategies to
target this addiction for therapy. These findings will likely have important implications in treating other cancers
with hyperactive Wnt and RAS/RAF for which no effective therapy currently exists.

Public health relevance
Project Narrative (PUBLIC HEALTH RELEVANCE) Colorectal cancer (CRC) represents a leading cause of cancer death in the US and worldwide. Developing targeted therapies for colon cancer has thus far been impeded by a lack of agents able to target the gate keeper mutation of APC loss or Wnt hyperactivation, and by the well-documented elaborate network of feedback activation of survival pathways triggered by mutant KRAS/BRAF. The proposed work will explore the convergence of these alterations on oncogenic translation and on metabolic and stress adaptation as an actionable and druggable vulnerability. The proposed work will develop and employ innovative tools and a highly mechanistic and translational approach to define the role of p-eIF4E, not eIF4E or global translation, in colon cancer biology and therapy. These studies are likely to advance basic understanding of colon cancer development, and discover potential biomarkers and novel drug combinations for treating advanced colon cancer and other cancers with hyperactivated Wnt and mutant RAS/RAF, for which no therapy currently exists.